2024 Fragile X and Autism-Related Disorders Gordon Research Conference and Gordon Research Seminar

Summary
Autism Spectrum Disorder (ASD) affects roughly 1% of the world’s population, and currently there are no
mechanism-based treatments that address the core features of ASD. It is now clear that the genetics underlying
ASD are complex; with several hundreds of genes conferring large risk as well as common variants contributing
to a large proportion of ASD heritability. Genetic studies of ASD suggest a high degree of convergence on
specific cellular processes and biochemical pathways, which have led researchers to posit that potential
therapeutic strategies may be shared across different genetic etiologies. The study of monogenic or syndromic
forms of ASD has been a leading strategy to gain insight into the complex mechanisms of ASD. Fragile X
Syndrome (FXS) is among the leading monogenic causes of ASD and is the most common inherited cause of
intellectual disability. Since the Fragile X gene (FMR1) was cloned in 1991, the field has used cellular assays
and model organisms to elucidate the functions of the FMR1 protein (FMRP), the consequences of its loss and
identify therapeutic targets for FXS and ASD. Other syndromic forms of ASD, such as tuberous sclerosis
complex, Rett Syndrome, Angelman Syndrome, and others, are being investigated using similar approaches.
Recent technological advances in stem-cell derived neurons, single cell sequencing, gene therapy, human
neurons and organoids are setting the stage for transformative advances in therapeutic development for these
neurodevelopmental disorders. This conference will bring together leading basic and translational scientists
studying ASD, Fragile X and related neurodevelopmental disorders from around the world with the ultimate goal
of developing mechanism-based treatments that address the core features of these diseases.

Public health relevance
Narrative Autism Spectrum Disorder (ASD) affects approximately 1% of the world’s population with no available mechanism-based therapies. Fragile X Syndrome (FXS) is the leading monogenic cause of ASD, the most common inherited cause of intellectual disability and can serve as a baseline for biological and genetic studies in the development of effective treatments. This conference will bring together leading scientists and clinicians studying FXS and autism-related disorders with the ultimate goal of identifying the molecular, cellular and circuit mechanisms responsible for underlying symptoms and how to best translate this knowledge into clinical trials.